Exercise, aging, and cognition: Effect and mechanisms

DESCRIPTION (provided by applicant): The goal of the proposed study is to investigate the cognitive effects of physical activity in two groups - young and older adults - aged 25-40 and 50-65. The great majority of controlled exercise studies in humans have been restricted to elderly individuals, typically age 65 and up. However, earlier intervention may be more beneficial for preventing or slowing age-related changes. Exercise studies in older adults have indicated that enhancing aerobic capacity has a beneficial effect on cognition, particularly executive control processes. However, the specific cognitive domains that are benefited may differ in younger and older individuals, since the most responsive domains in elders are those affected by aging. In the proposed 6-month randomized intervention study, 260 sedentary but otherwise healthy and cognitively intact individuals in these two age groups will be randomized into two treatment arms, aerobic exercise and stretching / toning. The potential effect of exercise on multiple cognitive domains will be examined with standard cognitive evaluations and computerized cognitive tasks. In addition, 3 levels of neuroimaging studies: structural MRI (for gray matter density), resting CBF (arterial spin labeling) and cognitive activation fMRI studies will be conducted at baseline and 6 months. We hypothesize that: 1) in comparison to the stretching / toning condition, aerobic exercise will produce improved performance on measures of cognition; 2) cognitive improvement will be noted regardless of age, although it will be greater in the older group; 3) in both younger and older participants in the aerobic condition, improvement will be more notable for tasks that tap executive control processes, such as set switching and working memory, compared to other cognitive domains; 4) improved in task performance will be accompanied by increased gray matter density, and increased efficiency of brain networks measured in fMRI studies. The proposed analysis of exercise effects at multiple levels will yield important insights onto the neural mechanisms underlying the beneficial effects of exercise. Because it may help prevent or delay cognitive aging, the possibility that exercise improves cognition in younger subjects has enormous potential significance for public health.

Public health relevance
PUBLIC HEALTH RELEVANCE: Evidence from animal and human studies strongly suggests that aerobic exercise has a beneficial effect on cognition, but controlled studies have been restricted to elderly individuals. The goal of the proposed study is to extend the investigation of the beneficial effects of aerobic exercise to younger individuals, aged 25-40 and 50-65. Earlier intervention may be more beneficial for preventing, as opposed to reversing, age related changes. Therefore, the possibility that exercise improves cognition in younger subjects has enormous potential significance for public health. NARRATIVE SUMMARY Evidence from animal and human studies strongly suggests that aerobic exercise has a beneficial effect on cognition, but controlled studies have been restricted to elderly individuals. The goal of the proposed study is to extend the investigation of the beneficial effects of aerobic exercise to younger individuals, aged 25-40 and 50-65. Earlier intervention may be more beneficial for preventing, as opposed to reversing, age related changes. Therefore, the possibility that exercise improves cognition in younger subjects has enormous potential significance for public health. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS While animal and human studies indicate cognitive benefits from aerobic exercise across the lifespan, the great majority of controlled exercise studies in humans have been restricted to elderly individuals. Those studies have indicated that enhancing aerobic capacity has a beneficial effect on cognition. One study suggests that this benefit is seen particularly for executive control processes, precisely the processes affected by aging. These improvements have been accompanied by increases in gray matter density and changes in fMRI patterns of task-related activation. The goal of the proposed study is to extend the investigation of the beneficial effects of aerobic exercise to younger individuals, and to compare these effects in young and old. There are several compelling reasons to evaluate this intervention in a younger population: 1) Earlier intervention may be more beneficial for preventing or delaying age related changes. This would have a major impact on public health. 2) Findings to date have focused primarily on individuals over age 65. Our extended age range will allow us to see if there is differential benefit in young (25-40) and younger old (50-65) individuals. 3) Younger individuals' cardiovascular function can benefit more rapidly and to a greater degree from aerobic conditioning. This may allow for greater cognitive benefit. In addition, this also allows us to study the temporal and quantitative linkage between cardiovascular and cognitive improvement. 4) The specific cognitive domains that are benefited may differ in younger and older individuals, since some reports suggest that the most responsive domains in elders are those affected by aging. In this application we propose to conduct a study in which 260 sedentary but otherwise healthy and cognitively intact individuals in 2 age groups, young (25-40) and younger old (50-65), are randomized to two training conditions, aerobic exercise and stretching/toning. Subjects will be assessed for aerobic capacity, cognitive task performance, and by structural MRI, resting cerebral blood flow scans (arterial spin labeling) and cognitive activation fMRI studies at study entry and after 6 months of training. We also propose two complementary approaches to investigating the neural correlates of the beneficial effects of aerobic exercise on cognition: 1) imaging -- we will use a combination of structural, metabolic, and cognitive activation fMRI studies to evaluate the neural substrates of the effect of aerobic exercise on cognition. 2) important correlates -- we will explore the effects of APOE genotype, inflammatory markers and cognitive reserve on the cognitive effects of aerobic exercise. We propose to test the following hypotheses: EFFECTS ON COGNITIVE FUNCTION 1. Aerobic training will lead to increases in cognitive performance in both the young and older subjects compared to the effect of the stretching/toning condition. 2. The increased cognitive performance will be most evident in the domains of executive control processes and working memory. 3. Improvement in cognitive performance will be greater in the older compared to the younger subjects. EFFECTS ON STRUCTURAL AND FUNCTIONAL IMAGING 4. Improved task performance will be accompanied by changes in the neural circuitry that underlie performance, as measured by fMRI. These changes will reflect more "efficient" functioning in the face of task demand. 5. Aerobic training will result in increased gray matter density, and will influence resting cerebral blood flow, particularly in those areas where flow is altered with aging. EFFECTS OF MODERATORS and MEDIATORS 6. APOE genotype will moderate aerobic exercise effects in all subjects such that those with APOE ε4 allele will show reduced cognitive benefits of exercise. 7. Effects of aerobic exercise will be mediated in part by reductions in measured inflammatory markers, including CRP, IL6 and TNF-a. 8. Higher measured cognitive reserve will be associated with increased benefit from aerobic exercise.